Access to Healthcare as a Driver of Place-Based Inequality in Mid-Life Mortality: Evidence from Movers in Medicaid

PROJECT SUMMARY
It is well-documented that where you reside in America shapes when you die, and this has been shown to be
particularly true among low-income Americans. These place-based inequalities in health have grown over time
in the United States, driven by increased mid-life mortality due to drug- and alcohol-related deaths and suicides.
While the drivers of this rise in mid-life mortality are complex and multifactorial, there is broad consensus that
the adoption of evidence-based treatments for substance use disorder and mental illness has the potential to
improve health and save lives. Despite their effectiveness, behavioral health services are generally thought to
be underused, with very limited access to these services in some regions of the country. We study the drivers of
place-based inequities in the Medicaid program, the primary source of insurance coverage and payer of
behavioral health services for low-income populations. This application seeks to understand whether and to what
extent place-based inequalities in mid-life mortality — and their gradients by gender and race/ethnicity — are
driven by the causal effects of place on access to evidence-based behavioral healthcare treatment by studying
the low-income population on Medicaid. Because families sort into areas based on a wide range of factors —
e.g., economic opportunity, amenities, cost-of-living, etc. — if people predisposed to poor (or good) health
outcomes tend to cluster in particular localities then observed health differences between areas may reflect this
non-random sorting (or “selection”) rather than the causal effects of place. To address this challenge, we use a
quasi-experimental movers research design that follows otherwise similar Medicaid enrollees residing in the
same place that move to different destinations. Subsequent differences in their healthcare utilization and health
can be attributed to place effects if movers are observed for a period of time before the move to adjust for
baseline outcomes. Second, to better under social gradients we stratify by sociodemographic characteristics and
recover the effects of places for distinct groups —comparing differences in the impacts of a place on different
groups reveals whether it tends to narrow or widen inequalities. Finally, we examine whether place-based effects
correlated with immutable characteristics of areas (e.g., climate) or features that are more readily amenable to
policy intervention (e.g., the healthcare delivery system). We make an original contribution, by advancing the
understanding of the relationship between “place” and health for low-income populations, with a focus on
understanding the role of differential access to high-quality, behavioral healthcare services.

Public health relevance
PROJECT NARRATIVE It is well-documented that where you reside in America shapes when you die, and this has been shown to be particularly true among low-income Americans where longevity varies substantially in different places of the country. This proposal studies Medicaid enrollees that migrate to understand whether “place-based inequalities” are driven by the causal impact of places on access to evidence-based behavioral healthcare treatment, and to identify the characteristics of places associated with improved access, health, and health equity.